Primate Veterinarian Training at the WaNPRC

[unreadable] DESCRIPTION (provided by applicant): Nonhuman primates (NHP) are critical to biomedical and behavioral research and their importance in biomedical and behavioral research is well documented. NHPs' close molecular, immunological, reproductive, and neurological relationship to humans makes them essential for biomedical research, testing and development efforts necessary to advance human health initiatives. The National Center for Research Resources (NCRR) and other NIH Institutes and Centers invest substantial resources in support of the National Primate Research Centers (NPRC) and other publicly funded NHP resources. Major support is also provided for basic and translational research using these species. Clinical veterinarians must receive additional training and experience beyond the professional training received in veterinary school in order to provide appropriate and quality clinical care and colony management. The increased demand for the use of NHPs in biomedical investigations, and emergence and spread of potentially deadly diseases such as SARS, influenza, and hepatitis that will be studied using NHP modes is expected to exacerbate the shortage of veterinarians who are properly educated in NHP clinical care and colony management. The purpose of this application to reduce this shortage of appropriately qualified veterinarians by requesting funding to provide support for training of three resident veterinarians over a four year period in all aspects of NHP nonhuman primate medicine, surgery, care, and management, as well as related areas such as basic NHP biology, genetics, behavior, pathology, production, and occupational health and safety. [unreadable] [unreadable] [unreadable]